Following the Sound of Music - Comparing the Effects of Music vs. Non-Music Based Interventions on Auditory and Cognitive Processing in Older Adults

PROJECT SUMMARY
There is no change from the Project Summary submitted in the parent application.

Public health relevance
PROJECT NARRATIVE There is no change from the Project Narrative submitted in the parent application.